Delivery of cytokines for cancer immunotherapy using nanolayer-controlled trafficking of liposomal nanoparticles

An immunosuppressive or immune excluded tumor microenvironment (TME) plays a key role in limiting the
response of many tumor types to immunotherapy. One attractive strategy to accomplish increased lymphocyte
infiltration in tumors is the use of cytokines, which can directly impact multiple immune pathways and reprogram
the TME to enable a robust immune response against cancer cells. Unfortunately, despite this obvious potential,
many cytokines have been limited clinically due to toxicity concerns. Rational drug delivery strategies that can
rescue the therapeutic potential of cytokines could act as an important step in our ability to carefully manipulate
the anti-tumor immune response in the TME and open the door for more effective immunotherapies. The layer-
by-layer (LbL) approach allows us to modify NP surface properties via electrostatically absorbed polymeric
coatings that promote specific cancer cell association and influence intracellular trafficking. In the first funding
period of this grant, we employed this strategy to target proinflammatory cytokines such as interleukin-12 (IL-12)
directly to OC cell surfaces. This therapeutic approach elicited robust CD8+ T-cell and NK cell infiltration into the
TME, and when coupled with combination checkpoint therapies (CTLA-4 and PD-1), this treatment strategy
yielded complete remission in a metastatic ovarian tumor model and promoted effective immune memory. The
successful improvement of IL-12 localization and retention within the TME demonstrated the potential of IL-12
as a monotherapy; however, in many cases, IL-12 alone is insufficient to promote curative responses and often
a combination treatment is needed. Messenger RNA (mRNA) provides a viable alternative approach to deliver
combinations of cytokines and engineered immunomodulatory therapeutics, as mRNA readily enables
combinations due to facile exchange of different nucleic acids and potentially lower systemic exposure of high
bolus doses due to prolonged and targeted expression. The rapid development of mRNA constructs and their
facile encapsulation into lipid nanoparticles (LNPs) allows for the rapid screening of therapeutic constructs in a
high throughput manner, whereas in contrast the use of an engineered protein therapy requires extensive protein
production optimization and purification steps. This mRNA-based approach will thus allow us to facilitate clinical
translation of cytokine therapies while introducing targeted mRNA production as a means of addressing systemic
toxicity. In this renewal, we seek to maintain or improve the extended duration of cytokine bioavailability
gained in current work, while facilitating combination cytokine therapies by developing layered lipid
nanoparticles (LLNPs) for the targeted delivery of cytokine-encoding mRNA to OC tissues. We will
develop, optimize, characterize and test LLNPs encoding for IL-12 cytokine, IL-12 fused to an anti-CD45 Ab for
targeting leukocytes in the TME, and (3) IL-12 fused to a GPI anchor. We will test these treatments in a range of
highly metastatic ovarian cancer models and leverage the platform to incorporate combination cytokines IL12
and IL15, as well as combinations with checkpoint inhibitors in orthotopic syngeneic animal models.
1

Public health relevance
Exciting new developments in cancer immunotherapy have led to measures that greatly lower cancer growth or even lead to complete elimination of tumors, including melanoma and certain forms of non-small cell lung cancer. Unfortunately, immunotherapies are not effective for advanced ovarian cancer due to significant challenges in activating the immune system against tumor tissues. In previous work, our lab has shown that presentation of natural inflammatory molecules that are very potent can cause immune cells to infiltrate the tumor; however these molecules can also be very toxic to healthy tissues. This work investigates the use of mRNA to program tumor cells to manufacture these immune-activating molecules through delivery in nanoscale carriers that can safely and directly deliver the mRNA to tumor tissues and initialize the immune response against the cancer while maintaining the health of normal cells and tissues.